Shared Resource Management

PROJECT SUMMARY/ABSTRACT
Perlmutter Cancer Center Shared Resources Management (PCCSRM) provides centralized oversight of the eleven (11) Perlmutter Cancer Center Shared Resources (PCCSR): the Applied Bioinformatics Laboratories, Biostatistics, Center for Biospecimen Research and Development, Experimental Pathology, Genome Technology Center, Immune Monitoring Laboratory, Metabolomics Laboratory, Microscopy Laboratory, Proteomics Resource Laboratory, Preclinical Imaging, and Rodent Genetic Engineering Laboratory. Each PCCSR is led by a PCC Shared Resource Director (PCCSRD), all of whom are NYU Grossman School of Medicine (NYUGSoM) faculty members, experts in their fields, and integral intellectual partners in Perlmutter Cancer Center (PCC) research projects from experimental design to assay development to data analysis. PCCSR deliver state-of-the-art services, develop and implement innovative methods and technologies, and are highly integrated and collaborative, enabling projects that require coordination of assorted technologies. They are heavily used by, and essential, to the four PCC Research Programs: nearly 70% (318) of all PCC publications during this funding period used at least one PCCSR. PCCSR are institutional resources of NYUGSoM, are supported by “chargeback” revenues and generous institutional subsidies and are tracked via a custom dashboard and iLabs. From 2018-2022, institutional investment in PCCSR was $46,179,896. PCCSR are led by Adriana Heguy, PhD, PCC Associate Director for Shared Resources. Heguy and her management team of administrators and PCCSRD continually assess the needs of PCC Research Programs via surveys and advisory board meetings. This oversight ensures that PCCSR services are high-quality and cost-effective, that access to services is equitable, that each shared resource (SR) provides training in key technologies to PCC members and their laboratories, that new SRs are developed when appropriate, and that underutilized or obsolete SRs are closed. PCCSRM continuously plans for the acquisition and implementation of new technologies and presents those plans to PCC and NYGSoM leadership to ensure continued investment in instrumentation and infrastructure for PCCSR. The Specific Aims of PCCSRM are: 1) To provide centralized infrastructure to ensure that all shared resources meet or exceed the expectations of investigators and support the multidisciplinary research mission of PCC, 2) To develop and support transparent mechanisms that educate, engage, and train PCC investigators in innovative technologies, experimental design, and ensuring data provenance, 3) To promote and facilitate research collaborations between the four PCC Research Programs and support best practices for data management and sharing for scientific rigor and transparency, and 4) To continuously assess the service needs of PCC members and interact with PCC and NYUGSoM leadership to ensure continued investment in instrumentation and infrastructure required to support basic, translational, and research.